ELECTROCHEMISTRY OF PROCAINAMIDE AND METABOLITES IN VITRO

Recent and current work indicate that the metabolites for procainamide are the important components responsible for the immune reactions. Electrochemical techniques allow for characterization of the different metabolites.